Decoding Nuclear Mechanosignaling and Epigenetic Mediators of Mechanical Memory in Cardiomyocytes

Project summary Mechanotransduction is the process by which cells convert external mechanical signals into
biochemical signals that shape their phenotypic adaptations. In cardiomyocytes, short-term extracellular
stiffening induces readily reversible phenotypic adaptations, while sustained exposure to extracellular stiffening
induces persistent changes in cellular structure and chromatin architecture: a phenomenon referred to as
'mechanical memory' (MM). We recently reported that stabilization of microtubule (MT) architecture is required
for both the formation and maintenance of MM in cardiomyocytes. In this proposal, I focus on the time-dependent
nuclear responses to extracardiac stiffening, including changes in chromatin architecture, gene expression and
DNA damage responses. My working hypothesis is that DNA damage is a central component of persistent
responses to extracellular stiffening and disease-relevant mechanical stresses. In Aim 1, I will determine the
molecular conduits and epigenetic regulators of MM using normal adult cardiomyocytes and a novel cell-culture
system with bidirectionally tunable stiffness. After defining the temporal and magnitude thresholds for inducing
MM, I will perform a whole genome ATAC-seq to determine the distinct epigenetic landscapes associated with
transience vs. persistence of the stiffness-induced phenotype in cardiomyocytes (K99 phase). Building on this
foundation, I will then determine the role of the DNA damage response (DDR) in determining the reversibility of
nuclear responses to extracellular stiffening. These studies will define whether DDR elements may be targets
for therapeutics to limit or reverse MM in CMs. In Aim 2 studies, I will translate these experiments to the tissue
level using living myocardial slices (LMS) from normal rat and human hearts. I will determine whether
pathomimetic increases in afterload evoke the same time-dependent MM responses, mechanotransduction
cascades, and DNA damage signals observed in isolated cardiomyocyte (K99 phase). I will then examine
whether interventions targeting MT dynamics and the DDR mechanism will attenuate afterload induced MM (R00
phase). Finally, in vivo studies will explore whether time-dependent MM dynamics, and mitigating strategies, are
relevant to the myocardial dysfunction observed in the viable myocardium following a large myocardial
infarction(R00 phase). Through the proposed work, I will significantly expand my expertise and facility with
several powerful and versatile skills (RNA-seq, ATAC seq, the LMS model, and rodent experimentation) while
broadening my ability to work with large datasets and manage a multifaceted research program. During this
process, I will pursue interactions and scientific connections with centers and collaborators within and outside
my institution that will contribute to the advancement and completion of this work and prepare me for success
as an independent research scientist.

Public health relevance
Project Narrative: The nucleus serves as the cells control center of forces and responds by regulating transcription that drives changes in cell fate. How cardiomyocytes nuclear signaling is affected by temporary physical forces is poorly understood, yet growing evidence suggests that aberrant chromatin and phenotypic changes persist despite the ceasing of the physical forces which might lead to long-term heart issues. This proposal aims to clarify how progression of diseased cardiomyocytes in the heart changes over time and whether it can be reversed by examining permanent DNA, epigenetic, structural, and functional changes in the myocardium and provide ways to help restore the heart’s health by reversing these load dependent persistent changes.